The Administrative Core of SDSU HealthLINK Center for Transdisciplinary Health Disparities Research

ADMINISTRATIVE CORE – Project Summary
Established in 2018, the SDSU HealthLINK Center (Center) seeks to augment investigator and partner
capacity, as well as institutional capacity, for minority health and health disparities (MHHD) research. Despite
many advances over the first five years of the Center, SDSU, SDSUIV, and community partner organizations
continue to have significant gaps in research administrative support critical for fostering innovative
transdisciplinary MHHD research and dissemination for the uptake of research to practices and policies. The
objective of Administrative Core (AC) is to create a sustainable infrastructure for innovative and impactful
MHHD research at SDSU, SDSUIV, and with community partner organizations by removing barriers, building
capacity, and fostering a transdisciplinary environment. We propose the following three Specific Aims that align
with the goals of the RCMI specialized centers: 1) support the advancement and retention of investigators
involved in MHHD research; 2) facilitate the exchange of ideas, best practices, and research tools and
resources for fostering innovative and rigorous research, and translation of evidence to practices and policies;
and 3) implement a comprehensive evaluation plan to assess investigator, partner, and institutional capacity to
conduct impactful MHHD research. To accomplish Aim 1, AC will implement an organizational and governance
structure that is compliant with SDSU, SDSUIV, SDSURF, and federal guidelines, collaborate with institutional
leaders to implement institutional support, including a faculty hire and faculty course releases; facilitate career
enhancement activities; and support mentor engagement. The AC will support implementation of activities
within the Research Capacity Core (RCC), Investigator Development Core (IDC), Community Engagement
Core (CEC), and Recruitment Core (RC) by providing support for hiring, fiscal management, use of facilities
and equipment, among other Center-wide activities. To accomplish Aim 2, the AC will facilitate the exchange of
ideas, best practices, and research tools and resources by maintaining a National Advisory Committee with
experts in relevant sciences, community-engagement, faculty development, as well as by supporting
communication and dissemination efforts, including with the RCMI Network. To accomplish Aim 3, the AC will
implement a comprehensive evaluation plan to assess seven constructs, including implementation,
engagement, and satisfaction with Center activities, as well as four measures of impact: impact on the
institution to support MHHD research, impact on investigators and partners to conduct and disseminate
findings from MHHD research, impact on the acquisition of extramural funding, and impact on innovations in
MHHD research and practice with implications for policy, system, and environmental change. The ultimate goal
of the Center is to contribute to reductions in health disparities and optimize health outcomes for all. The AC
contributes to this goal by creating an effective and efficient organizational system to support research.